Vanderbilt Biomedical Informatics Training Program

Vanderbilt University proposes a 5-year renewal of its Training Program in Biomedical Informatics and Data
Science. Established in 2001, the Vanderbilt program offers MS and PhD degrees in biomedical informatics,
nondegree postdoctoral training, and short-term training experiences. The program attracts excellent
applicants from a variety of backgrounds, both clinical and scientific, and has strong program outcomes in
terms of scientific productivity and successful careers in research. Vanderbilt's commitment to biomedical
informatics and data science has produced a uniquely rich and diverse research and training environment.
Department of Biomedical Informatics (DBMI) faculty include leaders in clinical informatics and translational
bioinformatics, as well as other subdomains of informatics including clinical research informatics, public health
informatics, consumer health informatics, biomedical data science, and people and organizational systems.
Faculty are well-funded with external grants, and many also hold part-time operational roles in Vanderbilt
University Medical Center that allow them to conduct both foundational and applied informatics research. The
MS and PhD degree programs include a core curriculum of courses in biomedical informatics structured
around core competencies in computer and information science, biomedicine, social sciences, and research
methodology. Degree-seeking students establish competency in these core areas and also pursue specialized
study in one of several application domains: clinical informatics, translational bioinformatics, or biomedical data
science. A new specialization in HIV informatics is being developed, in collaboration with the Tennessee
Center for AIDS Research and NIAID-funded researchers at DBMI. In addition, the program offers research-
intensive nondegree postdoctoral fellowships and a summer research experience. For the period 2023-2027,
Vanderbilt requests 17 full-time training positions and 4 short-term training positions (STTP). The full-time
training positions include 9 NLM-funded predoctoral positions for candidates pursuing the PhD and 6
postdoctoral positions with a training endpoint of the research-oriented MS. In addition, these full-time positions
will include 2 NIAID-supported positions in HIV informatics (1 predoctoral and 1 postdoctoral). The short-term
training positions will be used to engage graduate students from groups that are underrepresented in STEM +
computing in pathways leading to biomedical informatics training and careers. We will continue to promote
diversity through collaborations with HBCU institutions including Meharry Medical College and Fisk University.
The Vanderbilt Training Program in Biomedical Informatics and Data Science has a robust history of meeting
the NLM's objectives for biomedical informatics research training, and will continue to do so. Our graduates
have excelled in pursuing research to advance informatics as a scientific discipline and apply it to solve
problems in health and health care.

Public health relevance
Vanderbilt University proposes a 5-year renewal of its Training Program in Biomedical Informatics and Data Science, requesting 17 full-time training positions (9 predoctoral and 6 postdoctoral positions funded by NLM, and 1 predoctoral and 1 postdoctoral position in HIV informatics supported by NIAIDS) and 4 short-term training positions per year. This renewal will allow Vanderbilt to continue its successful training program to prepare the next generation of researchers at the forefront of biomedical informatics and data science.